X-ray Visualized Implanted Sensor for Prosthetic Joint Infection (X-VIS-PJI)

Abstract
Our goal is to fabricate and validate a novel pH-indicating sensor which can attach to a hip prosthesis with
integrated sensors that can detect and monitor hip infections using standard of care X-ray imaging. Hip
replacement surgeries are performed on millions of people worldwide each year. In the United States alone,
there were 450,000 total hip arthroplasties performed annually. Most of these surgeries are successful with no
complications. However, infections are a leading cause of failure, with an incidence of about ~0.5-2% of total
hip replacement surgeries. If detected early, these infections can be treated promptly with antibiotics and
surgical debridement. However, mature biofilms usually require implant removal to treat the infection, followed
by revision surgery with associated risks of morbidity, mortality, and large cost. Therefore, it’s important to
detect post-surgery infections early and monitor the effect of therapies for effective treatment. We have
developed novel pH-indicating sensors which can attach to a prosthesis, can measure local infection, and can
be quantified using a standard x-ray. This Phase I SBIR will apply these pH-indicating sensors to the femoral-
neck of a hip prosthesis and evaluate their utility in a sheep model. Our long term goal is to develop the first
device that enables noninvasive local pH measurements using plain radiography. Further development could
see the sensor integrated into the implant with further commercialization partnership. Our scientific premise is
that acidosis in vivo can be measured noninvasively by conventional radiography using a pH-indicating device
fabricated using hydrogels that respond mechanically to the presence of hydrogen ions. Preliminary studies
show sufficient response rate, and pH sensitivity in the expected physiological pH range. We will refine the
prototype in vitro and human cadaver models, and validate the sensor in vivo function using an animal hip
model in sheep. The proposed research is significant because it develops a noninvasive method to detect,
monitor, and study infection in situ with the ultimate potential for reducing morbidity, mortality and associated
cost from implant infections.

Public health relevance
Project Narrative This small business innovative research project develops a sensor that attaches to a prosthetic hip prior to implantation to detect infection early and monitor treatment. During infection, the joint fluid acidity (low pH) causes a radiopaque bead to move within our sensor, and the bead position (and corresponding pH) is determined using standard-of-care X-ray imaging. The work is relevant to public health as early detection of prosthetic joint infection can mitigate risks of morbidity, mortality, and cost.